ShEEP Request for iNSCOPIX nVue System

The brain is no longer considered a “black box” because new devices and genetically-
engineered biosensors have made it possible to monitor activity of cells deep in the brain.
However, the brain is comprised of many different types of cells, and a device is needed that
monitors activity of different types of cells adjacent to each other especially in animals actively
engaged in behavior. Over the last year a new breakthrough technology was made available - a
miniature microscope that weighs only 2g, makes it possible to monitor activity of two different
cells in freely-behaving rodents. This device identifies activity patterns of brain cells during
specific behaviors, allowing investigators to construct brain activity maps of specific brain
circuits regulating purposeful behavior. Researchers can determine how neurodegenerative
disease or specific conditions such as traumatic brain injury or substance abuse affects circuit
function.
The nVue miniscope system enables investigators to identify activity at the single cell
level and how dysfunctional activity at the local level can cause pathological behavior. However,
the necessary core instrumentation that would serve to measure critical indices of cell signaling,
quantification and imaging, are not currently available to an individual investigator at RHJ
VAMC. The instrumentation requested in this proposal will directly address this issue.
The underlying hypothesis of this proposal is that abnormal cell signaling in specific
brain circuits leads to pathological behavior. A device is needed to monitor activity of brain
circuits. This equipment will accomplish the following specific aims: i) image brain circuits
activated during purposeful behavior, and ii) identify change in circuit activity in response to
disease, substance abuse, and traumatic stress or brain injury. By mapping activity in local
circuits it will be possible to reestablish activity and restore normal behavior.

Public health relevance
An important goal of neuroscience is to identify how activity in specific circuits in the brain regulates purposeful behavior. A miniature microscope that uses dual-wavelength technology to peer into the brains of freely-behaving rodents is now commercially available, allowing investigators to monitor in real-time the activity of juxtapositioned brain cells. Using new genetically engineered biosensors, investigators can for the first time determine the activity of local circuits in normal versus pathological conditions.